Metabolic Mechanisms of Functional Neuroprotection in Epileptic Brain

DESCRIPTION (provided by applicant): The ketogenic diet (KD) is a high-fat, low-carbohydrate and low-protein diet designed to mimic the metabolic and biochemical changes seen during fasting (prominently, ketosis). The KD is remarkably effective in the treatment of medically refractory epilepsy but the underlying mechanism(s) have not been elucidated. Interestingly, in addition to proven anticonvulsant properties, there is growing evidence that the KD may enhance cognitive functioning in epileptic patients. Given the rising concern for neurobehavioral problems associated with intractable epilepsy, and the expanding recognition that anticonvulsant drugs can themselves impair cognition, there is an urgent need to develop novel interventional strategies. Ketone bodies have recently been shown to exert neuroprotective activity in several models of neurological disease. Similarly, we have shown that ketone bodies alone can reduce reactive oxygen species (ROS) formation in neocortex and prevent oxidative impairment of hippocampal long- term potentiation (LTP) in rats. Accordingly, we hypothesize that the functional neuroprotective properties of the KD-defined herein as anticonvulsant and/or nootropic-might be in part a direct consequence of ketone body action, specifically via ketone-mediated inhibition of a novel epileptic target, the mitochondrial permeability transition (mPT) complex. The fundamental goals of the proposed studies are to: (1) determine whether acute and chronic administration of ketone bodies can enhance cognitive function and preserve hippocampal LTP in epileptic mice; and (2) to demonstrate that the underlying molecular mechanism of action accounting for this beneficial effect is alteration of mPT. First, we propose to demonstrate that ketone body administration alone is sufficient to render functional neuroprotective effects in epileptic mice. Next, we hope to demonstrate that the pharmacological inhibition of the mPT complex- specifically through an interaction with the cyclophilin D binding site-is responsible for the neuroprotective effects of ketone bodies. For the proposed studies, we will employ standard video-EEG and cellular electrophysiological techniques, behavioral tests of spatial learning/memory function, and mitochondrial biochemical assays. The results of our investigations may lead to an improved understanding of the mechanisms underlying the functional neuroprotective effects of the KD in epileptic brain, and may provide novel avenues for future therapies for intractable epilepsy and for important related co-morbidities such as cognitive dysfunction - an area that is a current NINDS Benchmark for Epilepsy Research.

Public health relevance
PUBLIC HEALTH RELEVANCE: Patients with epilepsy often suffer from cognitive and mood difficulties, and there are currently no effective therapies to treat these problems. There is growing scientific evidence that ketone bodies, produced by the liver in response to a special anticonvulsant diet, possess functional neuroprotective properties and may be helpful in countering cognitive dysfunction as well as seizure activity. This proposal will explore a potential molecular mechanism through which ketone bodies might exert such effects. PROJECT NARRATIVE Patients with epilepsy often suffer from cognitive and mood difficulties, and there are currently no effective therapies to treat these problems. There is growing scientific evidence that ketone bodies, produced by the liver in response to a special anticonvulsant diet, possess functional neuroprotective properties and may be helpful in countering cognitive dysfunction as well as seizure activity. This proposal will explore a potential molecular mechanism through which ketone bodies might exert such effects. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: The ketogenic diet (KD) is a clinically proven treatment for medically refractory epilepsy. It is a high-fat, low-carbohydrate and low-protein diet designed to reproduce the early biochemical changes seen upon fasting. The hallmark feature of the KD is the rise in blood ketone bodies (notably, b-hydroxybutyrate [BHB], the major ketone body). The KD is remarkably effective against multiple seizure types, and there is mounting evidence that this intervention may exert both structural and functional neuroprotective effects. Importantly, the KD may enhance cognitive functioning in epileptic patients, perhaps independently of its effects on seizure reduction. Given the rising concern for co-morbid psychiatric and neurobehavioral problems associated with intractable epilepsy, and the expanding recognition that anticonvulsant medications can themselves impair cognition, there is an urgent need to understand and develop novel interventional strategies to deal with these debilitating problems. Recent experimental data suggest that ketone bodies exert neuroprotective activity in a variety of in vivo and in vitro models of neurological disease. We hypothesize that the functional neuroprotective properties of the KD - defined broadly herein as anticonvulsant and nootropic - might be in part a direct consequence of ketone body action, specifically via ketone-mediated inhibition of a novel target, the mitochondrial permeability transition (mPT) complex. The fundamental goals of the proposed studies are to: (1) determine whether chronic administration of ketone bodies can render anticonvulsant effects, enhance cognitive function and preserve hippocampal LTP in epileptic Kcna1-null mice; and (2) to demonstrate that the underlying molecular mechanism of action accounting for this beneficial effect is inhibition of mPT, more specifically through inhibition of cyclophilin D which is an integral component of the mPT complex. Toward these goals, the following specific aims are proposed: Aim #1: To demonstrate that ketone bodies alone - when administered chronically in vivo - mimic the anticonvulsant effects of the full ketogenic diet in epileptic Kcna1-null mice. Hypothesis #1a: We hypothesize that chronic in vivo administration of ketone bodies will produce an anticonvulsant effect similar to that seen with the full ketogenic diet. Hypothesis #1b: We hypothesize that chronic in vivo administration of either carbamazepine or phenobarbital will reduce spontaneous recurrent seizures in Kcna1-null mice, comparable to the ketogenic diet. Aim #2: To demonstrate that ketone bodies are protective against intrinsic impairment of hippocampal long-term potentiation (LTP) and spatial learning in Kcna1-null epileptic mice. Hypothesis #2a: We hypothesize that chronic in vivo administration of ketone bodies will protect against intrinsic impairment of hippocampal LTP in Kcna1-null mice. Hypothesis #2b: We hypothesize that chronic in vivo administration of ketone bodies will enhance hippocampal-dependent spatial learning/memory in Kcna1-null mice. Hypothesis #2c: We hypothesize that chronic administration of either carbamazepine or phenobarbital will not protect against intrinsic impairment of LTP and of spatial learning in Kcna1-null mice. Aim #3: To provide in vivo evidence that the functional neuroprotective effects of ketone bodies are due in part to an interaction with the mitochondrial permeability transition (mPT) complex. Hypothesis #3a: We hypothesize that in vivo administration of the mPT activator atractyloside will abolish the anticonvulsant effects of ketone bodies, but not of carbamazepine or phenobarbital, in Kcna1-null mice. Hypothesis #3b: We hypothesize that in vivo administration of atractyloside will reverse the protective effects of ketone bodies against intrinsic impairment of hippocampal LTP in Kcna1-null mice. Aim #4: To demonstrate that pharmacological inhibition of cyclophilin D, an integral component of the mitochondrial permeability transition (mPT) complex, underlies the functional neuroprotective effects of ketone bodies. Hypothesis #4a: We hypothesize that ketone bodies and NIM811 (which is a selective inhibitor of cyclophilin D) will raise the threshold for calcium-induced mPT in isolated mitochondria from the hippocampus of both wild-type and Kcna1-null mice. Hypothesis #4b: We hypothesize that chronic in vivo administration of NIM811 will mirror the anticonvulsant effects of ketone bodies in Kcna1-null mice. Hypothesis #4c: We hypothesize that chronic in vivo administration of NIM811 will protect against intrinsic impairment of long-term potentiation (LTP) in hippocampal slices from Kcna1-null mice.